MAP2K1 AND MAP2K2 IN ACUTE LUNG INJURY AND RESOLUTION

ABSTRACT
With the surge of ARDS cases associated with SARS-CoV-2 infection, there is an urgent need to understand
novel pathways involved in resolution of lung inflammation and injury to provide the basis for new therapeutic
approaches. Studies comparing rodent and human lung injury gene expression signatures reveal conserved
pathways, including MAPK/ERK activation during injury. More recently, we found a genetic polymorphism in
MAP2K2 associates with death in ARDS, suggesting a biological role in ALI recovery. We demonstrated that
MAP2K1/MAP2K2 (MEK1/MEK2) activation in macrophages promotes pro-inflammatory pathways and inhibits
reparative ones, making it a potential target to manipulate macrophage phenotypes in ALI. In preclinical acute
lung injury (ALI) models, inhibition of MEK1/MEK2 improves measures of ALI, including faster recovery of body
weight, reduced pulmonary neutrophilia, and greater reparative macrophage activation. These results suggest
that MEK pathways could be effective targets in ALI. To address the isoform and cell source driving this
improvement in outcome, we generated mice deficient in MEK1 in myeloid cells (LysmCre+Mek1fl). These mice
have no phenotype in naïve conditions, but experience 100% mortality with LPS-induced ALI using a moderate
LPS dose from which all wild-type mice recover. These mice have a similar early inflammatory response to LPS
but fail to turn off inflammation at later time-points. This phenotype can be completely rescued with IFNAR1
blockade, suggesting MEK1 suppression of type I interferon responses is critical for ALI resolution. We also
found sustained MEK2/p-ERK activation in the absence of MEK1, suggesting that MEK1 is critical for MEK2
deactivation to promote ALI resolution. In support of this hypothesis, we found that mice lacking MEK2 globally
or in the leukocytes compartment have faster ALI resolution. The proposed aims below outline our approach to
identify how MEK isoforms work in concert to regulate myeloid cell responses to better define and target a novel
regulatory pathway in ALI. In aim 1, we will determine MEK1 and MEK2 cell-specific roles and signaling
pathways in ALI and test our will test our hypothesis that MEK1 is required to deactivate MEK2 in alveolar
macrophages to promote resolution of lung inflammation. In aim 2, we plan to evaluate MEK1 and MEK2
interactions and mechanisms of MEK2 deactivation. We will use MEK1 mutants to test our hypothesis that
MEK2 is deactivated by binding to pT292 MEK1, and we will determine how these mutants alter macrophage
inflammatory (LPS) and reparative (IL-4) responses. In aim 3, we plan to test MEK1 and MEK2 degraders as
therapeutics in murine models of ALI. We will test our hypothesis that MEK2-specific degradation will result in
faster ALI resolution. These studies will advance our understanding of how the immune system stops
inflammation and promotes ALI resolution, revealing new therapeutic targets and approaches that could be
brought to the bedside.

Public health relevance
PROJECT NARRATIVE Macrophages are key orchestrators of inflammatory responses in the lung, and they are important contributors to ARDS and ARDS resolution. MEK1 and MEK2 are protein kinases that regulate important cellular functions, and our data implicate MEK pathways as key factors directing macrophage polarization and ALI duration. This proposal will uncover a novel pathway by which inflammatory diseases in the lung may be modified.